Accounting for pre-baseline selective survival in cross-national studies of the exposome in Alzheimer’s disease and related dementias: a novel bias assessment tool

PROJECT SUMMARY
Features of the exposome are likely key to the etiology of Alzheimer’s disease and related dementias (ADRD),
and cross-national exposome studies of ADRD have huge promise in this area. Cross-nationally harmonized
cohort studies of aging such as the US Health and Retirement Study (HRS) International Partner Studies and
their embedded Harmonized Cognitive Assessment Protocols (HCAPs) are prime potential data resources for
exposome-ADRD research. These cohorts include population-based study samples of the appropriate age
range for ADRD incidence, and have a wealth of interview, physical, cognitive, and biomarker assessments
alongside administrative and geographic data linkages. The international coverage and harmonized design of
the HCAP studies allow for novel triangulation of exposome data across diverse country contexts. The HCAP
data have great potential to strengthen causal inference and broaden the global evidence base on features of
the exposome and diversity in the mechanisms through which it may impact ADRD. However, exposome
research in the HCAP network is limited due to a common bias in cohort studies of aging that is unresolved by
research efforts to date: selective survival in the target population that occurs prior to the study baseline. This
bias is difficult to quantify, as most studies lack information on population members who would have been
eligible for the study, but who died prior to enrollment. In the United States, mortality rates of 20-30% are not
uncommon in studies of aging, and, crucially for efforts to triangulate associational data across populations,
age-specific mortality varies widely cross-nationally. Many features of the exposome are associated with
survival, making this form of selection bias a salient yet under-studied threat to the validity of exposome-ADRD
research. Indeed, our preliminary data indicate considerable selection bias that is differential across HCAP
studies. Our current objective is to address this bias by innovatively quantifying plausible magnitudes of pre-
baseline selection bias in exposome-ADRD research using the HCAP network data, and to develop a user-
friendly web-based app that will allow other researchers to understand the impacts of survival bias in their own
research on the exposome in relation to ADRD. We will first conduct country-specific simulation studies using
life table data on age-specific mortality and cognitive data from our harmonized HCAP scores to generate
plausible estimates for the magnitudes of pre-baseline selection bias that could affect results of exposome-
ADRD analyses in the HCAP network. We will conduct simulations for three key exposome factors thought to
be salient to ADRD, with plausibly differential associations with mortality across HCAP countries: main lifetime
occupational skill level, later-life exposure to air pollution, and later-life exposure to type II diabetes. We will
then build a user-friendly and comprehensive web-based selection bias analysis tool to be hosted on the
Gateway to Global Aging website, which will be an important research resource to help elucidate the role of the
exposome in ADRD outcomes and disparities across the HCAP network of studies.

Public health relevance
PROJECT NARRATIVE There is a critical need to improve the robustness of causal inference on the role of the exposome in Alzheimer’s disease and related dementias (ADRD). Cross-nationally harmonized data provide a major opportunity to evaluate the consistency of exposome-ADRD associations across diverse populations and contexts, but a key methodological limitation is selective survival that happens in target populations prior to study baseline. We will address this bias by innovatively quantifying plausible magnitudes of pre-baseline selection bias in exposome- ADRD research using the HCAP network data and developing a user-friendly web-based app that will allow other researchers to understand the impacts of this type of selection bias in their own research on the exposome in relation to ADRD. The goal of this work is to provide research resources that will help to elucidate the role of the exposome in ADRD outcomes and disparities from a global perspective.